The National Environmental Health Assoc. Approach to Reducing Foodborne Illness via Promotion, Communication, and Support of Retail Food Safety Stakeholders in Collaboration with Partner Associations

Enhanced collaboration and a harmonized national approach to food safety complements the New Era of Smarter Food Safety, a modernized approach, involving stakeholders at all levels of the food safety supply chain in the reduction of foodborne illness. We, the National Environmental Health Association (NEHA), will collaborate with three national associations to assist retail food regulatory programs in reducing foodborne illness. Our specific aims are: 1) Develop a national Food Code adoption strategy; 2) improve the approach, competency, and food safety culture amongst regulators; 3) increase enrollment, engagement, conformance in the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS); 4) improve foodborne outbreak investigation methods; 5) increase the number of establishments that have well-developed and implemented Food Safety Management Systems; and 6) develop a strategy to enhance communication and better tell our story. Collectively, the four partner organizations are the Retail Food Safety Association Collaborative, or the Collaborative. The Collaborative will work to develop and promote a Food Code Adoption Tool Kit to assist retail food regulatory programs in adopting the most current version of the FDA Food Code. We will develop an interactive map which identifies the states’ respective version of the Food Code, to assist in evaluation and targeting interventions. NEHA and the Association of Food and Drug Officials (AFDO) will improve foodborne illness outbreak response by creating webpages that serve as the primary, cumulative source of information on existing resources, tools, and trainings. NEHA and AFDO will also create a series of virtual, customizable presentations for jurisdiction needing training templates. A guidance document will be created by NEHA and AFDO to promote the practice of active managerial control, increasing the number of food establishments with effective programs. NEHA will support our association partners, the National Association of County and City Health Officials (NACCHO) and the Conference for Food Protection (CFP), to increase regulatory programs’ implementation of effective intervention strategies, promote enrollment in VNRFRPS, and conduct virtual meetings with stakeholders to identify and overcome barriers to risk-based inspections. We will enhance communications by providing web content designed to promote Collaborative successes, outputs and recognized best practices. Additionally, we will develop at least two recommendations to FDA on emerging food safety issues, publish at least one scholarly article intended to quantify and characterize successes, challenges and lessons learned. The Collaborative will leverage each partner organization to raise awareness of food safety principles, enhance compliance with rules and regulations, promote best practices and work towards a reduction in foodborne illness.

Public health relevance
RFA-FD-20-028 Project Narrative The public health significance of this cooperative agreement is that an informed, educated retail level workforce and local food industry will reduce foodborne illnesses caused by poor employee hygiene practices and inappropriate food handling procedures. The proposed collaborative approach leverages the existing environmental public health associations’ resources and collective expertise to promote the adoption and implementation of the most recent version of the FDA Food Code, provide tools, resources and support for the food safety regulatory workforce for foodborne illness investigations and support strong active managerial control programs. This proposal builds on the foundational principles of food safety, focusing on preventative measures at the retail level that will lead to higher rates of compliance with current food safety requirements and standards, thereby reducing foodborne illness.